MIELHSS - Research Education Core

Research Education Core Project Summary
The Massachusetts Institute for Equity-focused Learning Health System Science (MIELHSS) aims to
develop leading scientists in embedded research, accelerate innovation, and achieve widespread culture change
in human-centered, equity-focused learning health system (E-LHS) science. Our framework for training and
science aims to achieve the quintuple aim of healthcare: better health, improved patient experiences, care team
wellbeing, and health equity, at lower cost. The Research Education Core provides a robust high-quality
infrastructure of didactic, mentored, and experiential activities that allows for the application and mastery of
AHRQ LHS Core Competencies and PCORI methods and prepares the future workforce of embedded LHS
scientists. We propose innovative approaches to rapidly grow a diverse workforce of LHS scientists and provide
them with the critical skills that they need to effectively engage health systems, patients, and communities to
drive LHS advances in health equity. Specifically, our pathway approach to professional development across the
entire professional spectrum, from student to faculty, multiplies the benefit of the educational infrastructure and
applies a best practice in advancing diversity and equity in the workforce. Our training program, coupled with an
individual development plan (IDP), tailors training to the level of experience, provides a tool for career planning
and mentor conversations, and provides a shared understanding of outcomes and metrics to evaluate progress.
With health equity as our focus, our proposed training program is anchored in equity-focused data science aimed
at identifying and measuring equity-focused targets, processes, and outcomes and equity-focused health care
delivery science, including training in human-centered co-design (HCD) and equity-focused implementation
science. The robust mentored environment coupled with health system and community engagement provides
an optimal learning environment for embedded learning health scientists.

Public health relevance
Education Core Narrative The Education Core works with the Administrative and Data Cores, and Heath system and community partners to train embedded health system scientists and accelerate the conduct of equity-focused PCOR/CER to improve health system operations, quality, and health outcomes. Our educational infrastructure will: 1) create a stimulating environment to develop embedded LHS scientists from diverse backgrounds, 2) provide a novel intensive program of embedded research training featuring Human-Centered Design, and 3) provide meaningful experiential mentored learning in diverse settings.